Role of cortical catecholamines in regulating motivated behavior and striatal dopamine

Role of cortical catecholamines in regulating motivated behavior and striatal
dopamine
Abstract
Cognitive flexibility and goal-directed behavior are critical for normal functioning, and their
dysfunction is central to multiple neuropsychiatric conditions, including dementias associated with
neurodegenerative disease. Cortical catecholamines and prefrontal cortical (PFC) dopamine
receptors are potent regulators of cognitive flexibility and goal-directed behavior. In addition to
these cortical mechanisms, striatal dopamine is necessary for motivated behavior (Yin et al.,
2005); however, the cellular, molecular, and projection-specific heterogeneity of PFC projections
to the basal ganglia, the impact of individual PFC catecholamines, and how they regulate striatal
dopamine and motivated behavior, are not clear. A better understanding of the mechanisms by
which PFC and PFC catecholamine signaling regulate cortico-basal ganglia circuitry could lead
to novel therapeutic approaches for addressing cognitive dysfunction in neurological and
psychiatric disorders. Our central hypothesis is that cortical norepinephrine and dopamine play
distinct roles in regulating striatal dopamine dynamics and motivated behavior through PFC D2R+
and D1R+ sub-circuits. Our goal is to use intersectional chemogenetics, fiber photometry and
behavior to decipher the roles of NET and cortical catecholamines in the regulation of motivated
behavior and striatal dopamine dynamics. We will test our hypothesis using the following three
aims: 1) Determine the contributions of the norepinephrine transporter to cognitive flexibility and
striatal dopamine dynamics.2) Determine the contributions of norepinephrine vs. dopamine to
cognitive flexibility and striatal dopamine dynamics. 3) Determine the contributions of PFC D1+
and D2R+ pyramidal neuron subpopulations to striatal dopamine and cognitive flexibility.
The outcomes of this R01 proposal will provide a refined molecular and anatomical framework
describing the functional roles of individual PFC catecholamines in regulating PFC D1/D2R+
circuits, striatal dopamine dynamics and motivated behavior. Given that catecholamine
dysfunction is central to cognitive pathology of dementias, neurological and neuropsychiatric
diseases, our results may reveal novel mechanistic strategies for developing molecular- and
circuit-based therapeutics for these disorders.

Public health relevance
Cognitive dysfunction is central to neurological disorders such as PD and related dementias, and several psychiatric disorders. We will for the first time decipher the individual roles of cortical norepinephrine and dopamine in motivation, learning, and their contribution to cortico-striatal circuits and striatal dopamine dynamics. Through our proposed studies, we will not only advance our understanding of basic catecholamine biology in the brain, but also help devise innovative strategies to modulate activity of these neuromodulators and cortico-striatal subcircuits, and develop novel targeted therapies to counteract cortical catecholamine dysfunction in dementias and neurological disorders.